The myosin super-relaxed state and human dilated cardiomyopathy

Project Summary/Abstract
Dilated cardiomyopathies are a frequent cause of heart failure worldwide, characterized by reduced
systolic function and left ventricular dilation. Dilated cardiomyopathy has been linked to various causes, including
viral infections, drug abuse, endocrine dysfunction, and genetic mutations. Reduced effective myocardial
contractility presents as a symptom early in disease progression of dilated cardiomyopathy. Studying the
molecular basis of decreased contractility by investigating the myosin motors that power contractions can provide
important insight and allow testing of potential therapeutic modulation. Current therapeutics for dilated
cardiomyopathy (e.g., ACE inhibitors, β-blockers, etc.) target symptoms but do not attenuate the underlying
source of contractile dysfunction. At the molecular level, force generation in cardiac muscle is determined by the
number of myosin motors that bind to the actin thin-filament during the systolic rise of calcium. Once myosin
motors bind, myosins hydrolyze ATP and undergo conformational steps to generate force. Recent attention has
focused on the myosin biochemical super-relaxed state, an energy-conserving, auto-inhibited state of cardiac
myosin that determines the proportion of myosin motors available. Thus, the amount of myosin motors in the
super-relaxed state modulates the magnitude of myosin motors available to generate sarcomere power upon
activation. The stability of the super-relaxed state can be modulated by phosphorylation of regulatory light chain
and myosin binding protein C. Additionally, as force increases, stress on the thick filament rises resulting in the
release of myosin heads, allowing greater force production. A decrease in available myosin motors as a result
of a shift towards the super-relaxed state is a potential mechanism of systolic dysfunction in human dilated
cardiomyopathy and has yet to be fully investigated. Therefore, our central hypothesis is that depressed
contractile force in dilated cardiomyopathy results from increased myosins in the super-relaxed state (Aim 1)
mediated by depressed regulatory protein phosphorylation (Aim 2), which may be able to be reversed with the
use of myosin activators (Aim 3). To test our hypothesis, we will utilize the fluorescent ATP pulse-chase
technique to quantify the proportion of myosins in the super-relaxed state and test the effects of myosin activators
at short and long sarcomere lengths. Also, using Phos-TagTM western blotting, we will measure the
phosphorylation status of regulatory proteins. This proposal will provide novel insight into the effects of myosin
activators on the super-relaxed state, demonstrate fundamental aspects of myosin biochemical states, and their
role in the molecular basis of human dilated cardiomyopathy.

Public health relevance
Project Narrative Dilated cardiomyopathy is a common cause of heart failure that is associated with reduced cardiac contractility. This project tests the hypothesis that the contractile dysfunction results from the myosin motors being shifted towards a super-relaxed state where they cannot contribute to force-generation.